The Society for Research on Biological Rhythms Conference: Rhythms from Cell to Clinic

Project Summary
The Biennial Conference of the Society for Research on Biological Rhythms (SRBR) is the largest gathering of
chronobiologists in the world, welcoming more than 700 attendees and featuring approximately 600 scientific
presentations. Traditionally, nearly 50% of conference attendees have been trainees, making it a critical event
for supporting young investigators. For this reason, the meeting includes a full day of training in chronobiology
and professional development for students, post-docs, and junior faculty. The 2024 Biennial SRBR Conference
will be held from May 18 – 22 at the Sheraton Puerto Rico Hotel in San Juan and we are requesting partial
support for the meeting that will be used to provide travel awards for trainees in the field of biological rhythms
research and to support the attendance and participation of underrepresented minorities and trainees from low-
income backgrounds. Biological rhythms are deeply conserved phenomena that control myriad aspects of human
metabolism, physiology, and behavior. The SRBR conference has traditionally featured basic chronobiology
research conducted on a diverse array of organisms alongside translational research seeking to understand the
ways in which rhythms impact human health. This combination of basic and translational research has produced
a body of knowledge that is now poised to transform the way clinicians diagnose, treat, and prevent disease.
This new development, referred to as “Circadian Medicine,” will be a major focus of the SRBR 2024 conference,
whose theme will be “Biological Rhythms from Cell to Clinic.” The conference will bring together scientists from
a wide range of fields, working on a diversity of model systems and at many different levels of biological
organization. The goals of SRBR 2024 are to: facilitate the exchange of the latest research breakthroughs and
new developments in the experimental and analytical methods for chronobiology; expand the network of
chronobiologists beyond the bench and into the clinic by showcasing recent discoveries in Circadian Medicine;
support the professional development for the next generation of chronobiologists; and broaden participation in
the field of biological rhythms.

Public health relevance
Project Narrative Disruption of biological timekeeping is known to contribute to a range of disorders and the biomarkers used to diagnose disease and the effectiveness of treatment are strongly influenced by biological clocks. The 2024 Society for Research on Biological rhythms Meeting will bring together scientists from a wide range of fields, working on a diversity of model systems and at many different levels of biological organization. The goals of this meeting are to: (a) feature the latest research findings and methodological advances in the field; (b) showcase the emergence of Circadian Medicine; (c) support the professional development of trainees and junior faculty; and (d) broaden participation in the field of biological rhythms.